Stanford Aging & Ethnogeriatrics Transdisciplinary Collaborative Center (SAGE)

PROJECT SUMMARY/ABSTRACT: The COVID-19 pandemic is having a devastating effect on our elderly population living in long-term care facilities, such as nursing homes. In particular, care for patients with Alzheimer’s Disease and related dementias (ADRD) is extremely challenging due to their special needs and difficulty adhering to social distancing requirements. This administrative supplement under the Stanford Aging and Ethogeriatrics (SAGE) Research Center (P30 AG059307) will examine the emotional distress caused by the COVID-19 pandemic and its impact on dementia risk in racial minorities. Aim 1 will examine the extent to which COVID-19-imposed emotional distress mediates the association between childhood social distress and late-life increased risk of dementia by race. Aim 2 will examine the mental health and coping strategies of aging minority residents in nursing homes during the COVID- 19 pandemic by recruiting respondents in nursing homes in selected segregated Metropolitan Statistical Areas (SMAs). These results are expected to shed new light on the extent to which the COVID-19 pandemic is exacerbating the effects of emotional distress on minorities living with dementia and how coping strategies may help to mitigate that risk and the provision of dementia care. Our results from both Aims will be integrated and complement each other by providing robust statistical evidence on the association between stress and ADRD as well as first-hand evidence and perspectives from residents and caregivers, who are currently at the frontline of the COVID-19 pandemic.

Public health relevance
Project Narrative: The COVID-19 pandemic is likely taking an enormous toll on the mental health of elderly minority patients and their caregivers in long-term care facilities. The results of this administrative supplement project will provide significant insights into the emotional impact of the pandemic on patients with Alzheimer’s and related dementias and ultimately lead to the design of more effective coping strategies for handling stressful events and improve the overall provision of care.